Investigating the redox-sensitive E3 ubiquitin ligase Pellino-1 as a driver of T-cell dysfunction during severe lung infection

PROJECT SUMMARY
Patients with hematologic cancer are at increased risk of morbidity and mortality from severe lung infections due
to both disease and treatment-associated defects in cell-mediated and humoral immunity. CD8 T cell immunity
is critical for survival from these infections, as evidenced by our laboratory’s findings in patients with hematologic
cancer and severe COVID-19 infection. However, persistent antigen exposure during severe infections leads to
loss of T-cell cytotoxic effector function and proliferative capacity, leading to inefficient pathogen clearance.
Therefore, strategies to reverse CD8 T cell dysfunction represent a critical unmet need in patients with
hematologic cancer and severe lung infections. Our laboratory previously demonstrated that mitochondrial redox
stress drives CD8+ T-cell dysfunction during persistent antigen exposure in a manner that can be reversed by
the antioxidant N-acetylcysteine (N-Ac) and recently completed a clinical trial of N-Ac in cancer patients with
severe COVID-19 infection. In my preliminary studies, I found that circulating CD8 T cells from patients with
cancer and severe COVID-19 had significantly reduced expression of Pellino-1 (PELI1) following N-Ac treatment.
PELI1 is an E3 ubiquitin ligase known to negatively regulate CD8 T-cell activation. However, its role in limiting
CD8 T-cell function during severe infections remains unknown.
Therefore, my hypothesis is PELI1 is a redox-sensitive E3 ligase that limits CD8 T cell immunity during severe
respiratory infections by selectively degrading substrates essential for self-renewal and cytotoxicity. We will
address this hypothesis through the following Specific Aims. In Aim 1, I will test the hypothesis that PELI1 limits
CD8+ T cell immunity during severe respiratory infections in vivo, by analyzing primary samples from
hematologic cancer patients with a variety of respiratory infections as well as by determining the impact of PELI1
knockout on T-cell mediated pathogen clearance in mouse models of severe pneumonia. In Aim 2, I will
determine the mechanism by which PELI-1 restricts CD8+ T-cell function during persistent antigen exposure. By
performing biochemical and proteomic analyses to identify both PELI1 substrates and redox-dependent post-
translational modifications in PELI-1 to gain insight into mechanisms of PELI1 function and regulation. The
information obtained from this project will lay the groundwork for understanding of how redox regulation impacts
T-cell dysfunction, thereby paving the way for innovative therapeutic strategies for patients with severe
respiratory infections, including those with concurrent hematologic cancers.

Public health relevance
PROJECT NARRATIVE Sustained CD8 T cell function is required for the survival of patients with hematologic malignancies and severe lung infections. Our preliminary data demonstrates a role for Pellino-1 in mediating redox-dependent T cell dysfunction in cancer patients with severe COVID-19 infection. By understanding how Pellino-1 limits T cell function during persistent antigen exposure, the work in this proposal will reveal novel therapeutic targets to improve T-cell mediated control of respiratory infections, particularly in patients with hematologic cancers.